Modeling of Collateral Perfusion in the Ischemic Brain

PROJECT SUMMARY/ABSTRACT Common neurological disorders pose an increasingly formidable public health burden that requires studies of underlying mechanisms and ample effort of patient-oriented research (POR) investigators. This midcareer application's long-term mentoring program goal is to train leading young translational scientists from diverse neurologic subspecialties in POR, redressing the mentoring gap in neurology POR that threatens future progress, and the long-term research project goal is to increase understanding of collateral perfusion in stroke. An innovative mentoring infrastructure for selected residents, clinical fellows and junior faculty is proposed with content mentors in neurologic subspecialties and an overall POR mentor. Mentoring aims include 1) establishing departmental mentoring infrastructure, one-on-one mentoring, trainee research, career development and website resources; 2) creating new courses on neurology clinical and translational research and scientific communications; and 3) continually enhancing faculty mentorship skills. The impact of this mentoring program at UCLA will be tracked with specific outcome measures to ensure achievement of trainee and overall program milestones. This K24 award will help achieve departmental long-term goals to enhance POR across neurologic subspecialties, establish formal neurology POR mentorship, stimulate independent research of trainees and foster an inspiring intellectual environment to increase the number of future neurology POR investigators. This integrated approach to neurology POR training also benefits from a focused research strategy to develop a model of collateral perfusion for content mentoring in stroke, a project that provides mentoring opportunities over a diverse spectrum of POR techniques. Novel neuroimaging and angiography approaches will be used to develop and validate a regional model of collateral perfusion using pressure differentials in arteries, tissue, and veins to predict tissue fate and neurological outcomes in acute ischemic stroke. This clinically relevant work on an important topic in stroke care will enhance understanding of collateral perfusion, including the distinct contributions of arterial and venous segments of the cerebral circulation. In addition to the advancement of scientific knowledge and provision of mentoring opportunities, a tangible resulting product will be a software tool to enhance prediction of tissue fate and neurological outcomes in acute stroke across diverse causes of brain ischemia.

Public health relevance
PROJECT NARRATIVE/!RELEVANCE TO PUBLIC HEALTH STATEMENT Understanding mechanisms of neurological disorders such as stroke and mentoring trainees in patient-oriented research are key priorities for improving public health. The mentoring program outlined in this proposal wil train a new generation of researchers in translational and clinical neuroscience. An exemplar study will investigate collateral perfusion (blood flow around blockages in the brain), developing a realistic model of collateral perfusion in stroke using magnetic resonance, computed tomography, and catheter angiogram imaging technologies. This model may be used to guide and enhance future treatment strategies. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Common neurological disorders pose an increasingly formidable public health burden that require studies of underlying mechanisms and ample effort of patient-oriented research (POR) investigators to improve potentially debilitating outcomes.37 To met this chalenge, this aplication has two long-term goals: to implement an innovative mentoring program that will educate trainees across neurologic subspecialties in neuroscience POR (NPOR) and in the specific arena of vascular neurology, to advance pathophysiologic understanding and therapeutic applications of collateral perfusion in stroke.21 The NPOR Mentoring Program recognizes that all neurology subspecialties share techniques and challenges in POR, including advanced neuroimaging, the blood-brain barrier, the genetics of behavior, and the assessment of outcomes in brain- compromised individuals. Residents, fellows, and junior faculty pursuing NPOR require training in neuro- specific domains that does not exist within general medical POR training programs such as the UCLA Clinical and Translational Science Institute (CTSI). A mentoring infrastructure for selected residents, clinical fellows and junior faculty is proposed with content mentors in neurologic subspecialties and an overall POR mentor that coordinates mentoring via an educational curriculum based on common methodologies. Active engagement in NPOR is important for the program director, to keep skills sharp and knowledge of trends in the field up to date. This application therefore also outlines a 5-year research program to develop and clinically apply a multimodal model of collateral perfusion. Retrospective and prospective cohort studies will use novel neuroimaging and angiography approaches to develop and validate a regional model of collateral perfusion using pressure differentials in arteries, tissue, and veins to predict tissue fate and neurological outcomes in acute ischemic stroke. The resulting software tool will address important mechanisms of collateral perfusion in a variety of stroke etiologies or causes. This research provides concrete grounding in diverse domains important for broad NPOR mentoring, including neuroimaging, blood brain barrier disruption, prognostic model development and refinement, and outcomes research. Mentoring Aims Specific Aim 1: To create a rich training structure to support the growth of neurology residents, clinical fellows and junior faculty as independent investigators in NPOR (infrastructure). An essential infrastructure for mentoring trainees in neurology POR at UCLA will be established, including departmental mentoring Core Faculty, research presentation development and forums, a career development course, and a web community. Specific Aim 2: To provide formal coursework and lectures to trainees on core competencies in neurology clinical and translational research (content). Three NPOR courses will be created that will address neuro- specific curricula on translational research, responsible conduct of research and scientific communications. Specific Aim 3: To further enhance mentoring and assess effectiveness of NPOR training (impact). Formal plans are established for further enrichment and dissemination of mentoring skills, using departmental, campus, and external expertise and resources at a national level. Research Aims Specific Aim 1: To determine the role of arterial collaterals on downstream perfusion in the ischemic territory. We will test the hypothesis that arterial collaterals on angiography do not correlate with CT/MRI measures of delayed downstream perfusion (identify flow abnormalities in retrograde leptomeningeal flow that cause delay). Specific Aim 2: To determine the role of microcirculation & venous hemodynamics in collateral perfusion. We will test the hypothesis that collaterals are associated with microcirculatory changes & venous hemodynamics that are influential in collateral perfusion and the resultant tissue fate of infarction. Specific Aim 3: To develop & validate a model of collateral perfusion based on regional pressure differentials. We will test the hypothesis that across diverse stroke etiologies, regional variation in pressure differentials of arteries, tissue and veins can be used to model collateral perfusion in acute ischemic stroke from MRI data and accurately predict tissue fate of infarction and associated neurological outcomes with a novel software tool. This K24 award will help achieve long-term goals to enhance NPOR, establish formal NPOR mentorship, provide resources for mentee independent research and create an inspiring intellectual environment needed to increase the number of future NPOR investigators. Overall impact of these closely integrated objectives of NPOR mentoring and content mentoring at UCLA will be tracked with specific outcome measures to establish evidence of additional trainee attainment of NPOR career milestones. Individualized trainee mentoring will be assessed by academic achievements including grant submissions, funding of additional proposals, publications, career development goals and faculty promotions. The concrete research project on NPOR in stroke care will enhance our understanding of collateral perfusion, including pivotal mechanisms from arterial to venous segments of the cerebral circulation, facilitating development of an accurate software prediction tool.